Administrative Core

Administrative Core - SUMMARY/ ABSTRACT
The responsibilities of the Administrative Core include monitoring and planning of scientific activities, providing
scientific direction for the SPORE, ensuring an interdisciplinary translational research emphasis and integration
within MD Anderson and NCI Translational Research Programs. The Administrative Core is managed by two
co-directors (Drs. Laura Beretta and Ahmed Kaseb) who will preside over the scientific quality of the SPORE
and ensure communication, cooperation, and integration between components of the SPORE. Administrative
duties will be managed by Dr. Tiffany Calderone, Program Coordinator, who will oversee the SPORE activities
and budget. Ms. Lynne Nugyen and Ms. Cassandra Harris, Project Director and Health Education Manager,
respectively, in the Center for Community-Engaged Translational Research, will facilitate recruitment of
minorities and women to the SPORE clinical trials and will serve as the community liaison for outreach efforts.
Ms. Ersulan Hampton, Project Director in Translational Research Administration, will serve as a consultant for
joint initiatives with other MD Anderson SPORES and the Institution CCSG. The Administrative Core provides
leadership and coordinates the activities of the Executive Committee (which consists of all Project co-leaders
and Core co-directors), the Internal Advisory Committee, the External Advisory Committee, and the SPORE
Advocates. The objectives of the Administrative Core are: 1) to oversee all projects and cores; 2) to oversee
the Developmental Research and Career Development programs; 3) to convene all meetings of the SPORE
Executive Committee, Internal/External Advisory Committees, and Advocate Advisory Committee; 4) to
schedule and organize all necessary meetings, including monthly scientific meetings, lectures, symposia, and
attendance at any NCI-sponsored meetings/workshops; 5) to coordinate data quality control and quality
assurance in conjunction with the Internal Review and Monitoring Committees of MD Anderson, 6) to monitor
and oversee all fiscal and budgetary issues; 7) to initiate collaborative research with other SPOREs through
electronic communications or joint meetings; 8) to communicate with the NCI Project Officer and other NCI
staff to prepare all required reports and publications; 9) to notify the NCI Project Officer promptly of important
developments that affect the management of the SPORE either positively or negatively; 10) to assure
compliance with all general, governmental, and NCI regulations and requirements; and 11) to establish and
implement policies for recruitment of women and minorities. Additional objectives of the Administrative Core
will be to organize with the support of UT System and MD Anderson, annual scientific conferences on HCC
and annual community events directed to minorities and underserved populations in Texas particularly affected
by hepatocellular carcinoma. .

Public health relevance
Administrative Core - NARRATIVE The Administrative Core interfaces with the NCI and provides scientific, administrative and financial oversight for all Projects and Cores and the Developmental Research and Career Enhancement Programs of the MD Anderson Hepatocellular Carcinoma SPORE.